Identifying Chemo-Neoepitopes for Immunotherapy Interventions Against Triple-Negative Breast Cancer

PROJECT SUMMARY/ABSTRACT
Patients with advanced triple-negative breast cancer (TNBC) have a poor prognosis, with a median overall
survival of ~18 months with standard-of-care (SOC) chemotherapy. However, overall survival can be extended
in such TNBC patients, albeit, modestly to ~25 months with a combination of SOC and immunotherapy, reflecting
the rationale that the immune system is an integral player in the overall anti-cancer response. In TNBC, the
immunotherapy, known as an immune checkpoint inhibitor (ICI), is a monoclonal antibody that blocks the PD-
1/PD-L1 axis in CD8+ cytotoxic T lymphocytes (CTLs) to sustain their effector function. A prerequisite for effective
ICI therapy is the availability of tumor antigens (Ags) which, in turn, are recognized by the Ag-specific CTLs. We
now know that a positive effect of certain chemotherapeutics on ICI efficacy is due in part to the availability of
‘neo-Ags’ recognized by CTLs. These neo-Ags are thought to derive from therapy-induced mutations or,
perhaps, to non-mutated determinants generated by post-translational protein modifications induced by
immunogenic cell death. However, chemotherapy can generate yet another type of non-mutated neo-Ag which
is currently overlooked. Chemotherapy mediates antitumor effects because cancer cells respond differently from
normal cells to DNA damage. These interventions damage not only DNA, but also RNA components of the
spliceosomes. Consequently, chemotherapy can be accompanied by a transient inhibition of splicing exposed
as widespread intron retention. The pattern of DNA damage-induced intron retention is recurrent and
reproducible in cells treated with the same chemotherapy. Translation of mRNA transcripts harboring retained
introns results in generating shared non-mutated neo-Ags encoded by intronic sequences. Differential responses
to chemotherapy-induced DNA damage manifested as repression of transcription for a set of cell replication-
related genes in normal cells, but not in cancer cells with p53 gene mutations, is frequently the case for TNBC.
This may result in generating cancer-specific, non-mutated neo-Ags encoded by retained introns. Some of these
novel intron-encoded sequences may contain immunogenic neo-epitopes that can be recognized by CTLs. Here,
we hypothesize that chemotherapy treatment of p53-mutant tumor cells generates novel ‘chemo-neoepitopes’
(CNEs), which can be identified and used as immunogens to mobilize new pools of tumor-specific CD8+ T cells.
Our rationale reflects the concept that the CNE peptide sequences would be completely new to the immune
system and would be capable of generating robust immune responses. In this proposal, we will identify candidate
CNE peptides in Aim 1, and then in Aim 2, determine their immunogenicity and the breadth of the induced CD8+
T cell repertoire. Immunizations that elicit a CD8+ T cell repertoire similar or identical to that induced by the
chemotherapy paradigm will suggest a novel CNE. Our long-term objectives are to increase the frequencies of
antitumor CD8+ CTLs and ICI efficacy in TNBC, a disease with still unmet clinical challenges.

Public health relevance
PROJECT NARRATIVE While patients with advanced or metastatic triple-negative breast cancer (TNBC) have a poor prognosis, survival can be extended, albeit, modestly using a combination of chemotherapy and immunotherapy, known as ‘chemo- immunotherapy’, reflecting the longstanding rationale that the immune system can be an integral player in the overall anti-cancer response. Here, we are testing a novel approach in preclinical models of TNBC, one based on the identification of new tumor antigens generated by the chemotherapy insult, which will then be utilized as a ‘vaccine’ to immunize the host potentially enriching the breadth of the anti-cancer immune response. Overall, immunization against these novel tumor antigens, termed ‘chemo-neoepitopes’, has the potential to enhance the efficacy of existing regimens and, thus, may have important implications for expanding treatment options for patients with advanced or metastatic TNBC receiving standard-of-care alone.